Technology Research and Development Project 3 (Characterizing and Modifying Cortical Processes)

Neurological disorders affect millions of people in the United States and worldwide. Better understanding of the
short-term changes and the persistent changes that result from precisely targeted electrical stimulation of brain
networks can lead to novel technologies that improve diagnosis and treatment of these disorders.
Intracranial recording/stimulation techniques using electrocorticographic (ECoG) electrodes on the brain surface
and/or depth electrodes (stereoencephalography (SEEG)) provide a powerful method for spatially and temporally
precise recording and stimulation, but current stimulation protocols are based largely on trial-and-error and thus
are probably suboptimal. Taking optimal advantage of ECoG/SEEG requires the ability to design adaptive record-
ing/stimulation protocols that induce speciﬁc beneﬁcial changes in the brain processes underlying behavior. The
work proposed here will address this need by creating a stimulation-based system that can map cortical/subcortical
functional networks and can modulate these networks so as to restore brain function.
TR&D3's long-term goal is to develop and iteratively optimize a new generation of adaptive neurotechnologies that
can introduce predictable changes in brain networks, and to clinically test the efﬁcacy of those technologies for
alleviating the devastating effects of neurological disorders such as stroke. To achieve this goal, TR&D3 has two
Speciﬁc Aims:
Aim 1. To establish the short-term changes in network activity and resulting behavior that are produced by electrical
stimulation. Aim 1 comprises two studies. The ﬁrst study will use electrical stimulation to establish which and
how brain networks are activated by electrical stimulation of speciﬁc locations. The second study will determine
how input produced by electrical stimulation interacts with moment-by-moment variations in cortical excitability to
produce population-level responses.
Aim 2. To establish the persistent changes to network activity resulting from electrical stimulation. The ﬁrst study
will determine to what extent stimulus-induced changes modify behavior in the short term and the long-term. The
second study will assess the dependence of these changes on stimulus amplitude.
These two aims will produce a stimulation-based functional imaging system. To validate and optimize this novel
system, TR&D3 will engage in two collaborative projects with scientists at the University of California (Berkeley)
and at MIT. Together, these collaborations will establish the effectiveness and value of the new stimulation-based
functional imaging system.
By accomplishing these aims, TR&D3 should produce new understanding of how electrical stimulation produces
short-term and persistent changes in brain function. It should also create a new clinical system that can map
brain networks and can target speciﬁc beneﬁcial changes in function. Thus, this work should increase scientiﬁc
understanding and enhance treatment for a range of neurological disorders.